Preclinical Studies of Living and Deceased Donor Liver Allograft Tolerance

PROJECT SUMMARY
Acute rejection following liver transplantation (LTx) occurs in up to 30% of recipients and is associated with
significantly increased risk of graft failure, graft failure-related death, and all-cause mortality. Induction of liver
tolerance would decrease these risks and the toxicities associated with immunosuppressive medications.
Although rare, spontaneous tolerance after LTx can be achieved in immunosuppression withdrawal studies.
Broad application of this approach is limited by the lack of knowledge about the mechanism(s) of tolerance,
markers for tolerance, and therefore the lack of rational targets for immune induction therapy to increase the rate
of tolerance. To address these gaps, we developed a nonhuman primate LTx model to test induction strategies
for liver tolerance. Preliminary data in our model demonstrated that transient donor chimerism failed to lead to
liver tolerance. LTx without bone marrow transplantation but with memory T cell depletion also failed to induce
tolerance. These results demonstrate that alternate strategies are required to induce tolerance to livers. We now
propose to achieve liver tolerance by inducing durable donor mixed chimerism with conditioning protocols
designed for use in living and deceased donor settings. Our long-term goals are 1) to develop clinically applicable
protocols for tolerance induction after living or deceased donor LTx; and 2) to define the mechanism by which
tolerance develops. Our central hypothesis is that induction of durable mixed chimerism without GVHD will result
in tolerance. The proposed research is innovative because it utilizes a translational animal model to develop a
clinically applicable tolerance induction protocol. It will also use innovative techniques to characterize the donor-
specific immune response to liver transplants, and the interaction of graft-infiltrating lymphocytes and recipient
antigen-presenting cells. In Aim 1, we will test the ability of Bcl-2 inhibitors to promote durable chimerism for
simultaneous bone marrow and liver transplants while reducing the toxicity of the induction regimen. We will also
determine the effect of immunosuppression duration on the subsequent rates of tolerance and rejection. In Aim
2, we will attempt to induce durable mixed chimerism with delayed immune conditioning and donor bone marrow
transplant for 4 months after the LTx. This approach would be applicable for frail recipients or recipients of
deceased donors. In Aim 3, we will adapt our laboratory’s high-throughput alloreactive TCR sequencing assay
to the cynomolgus model to track and analyze the activation of donor-reactive effector and regulatory T-cell
clones after transplant. We will also characterize the transcriptome of graft-infiltrating T cells and APCs from liver
biopsies to determine if (and how) the liver promotes tolerance. These mechanistic studies will have a positive
impact by revealing potential biomarkers of tolerance. They will also allow us to refine our induction protocol to
minimize toxicities. Upon successful completion of the proposed research, we expect to develop tolerance
induction regimens for living and deceased donor LTx. These achievements would be significant as withdrawal
of immunosuppression early after LTx would result in improved patient survival and quality of life.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to human health since liver transplantation is the only treatment for end-stage liver disease, but transplant outcomes are limited by rejection, infection, increased risk of cancer and toxicity related to immunosuppressive medications. This project uses novel strategies to induce and define the mechanism of tolerance to liver transplants in our unique nonhuman primate liver transplant model. This is relevant to the mission of the NIH as it seeks to develop clinically applicable tolerance induction protocols and to define the mechanisms that drive the immune response following liver transplantation.